Regulation of gasdermins through protease processing and other post-translational modifications.

Abstract
The long-term research program in the Xiao lab focuses on structural and biochemical studies of innate immune
signaling, particularly the inflammasome pathways. Activation of inflammasomes may lead to the maturation and
secretion of proinflammatory cytokines IL-1b and IL-18, as well as pyroptosis. Pyroptosis is a highly inflammatory
form of cell death mediated by gasdermin D (GSDMD) and other gasdermin family members downstream of
diverse signaling pathways implicated in infections and autoimmune or autoinflammatory disorders. As such,
understanding the mechanisms of gasdermin regulation is highly significant. Despite recent progress on the
identification of gasdermins as effectors of pyroptosis, and on the mechanisms of GSDMD activation by
inflammatory caspases, contributed by the Xiao lab and others, the molecular mechanisms underlying the
regulation of gasdermin function remain incompletely understood. In particular, gasdermin processing by
different caspases and other proteases that may activate or suppress pyroptosis remain understudied. Even
though protease processing, an irreversible form of post-translational modification (PTM), is the most intensively
studied mechanisms of gasdermin regulation, emerging evidence suggests that gasdermins are regulated by
several other PTMs such as ubiquitination and Cys modifications. The regulation of gasdermins by host and
microbial proteases, ubiquitin ligases, and palmitoyltransferases remain key knowledge gaps that have
hampered mechanistic understanding of pyroptosis regulation under physiological and pathological conditions.
This proposal is based on emerging evidence from the rapidly evolving field of gasdermin biology that serve as
strong scientific premise and rationale. The proposed studies leverage our expertise in structural and
biochemical studies of gasdermin activation by inflammatory caspases, and target critical gaps in our
understanding of gasdermin regulation using complementary structure-function approaches. We hypothesize
that post-translational modifications of gasdermins by host and microbial enzymes, such as proteases,
ubiquitin ligases, palmitoyltransferases, and other enzymes, regulate their function in pyroptosis. Better
understanding of how gasdermins are regulated will not only furnish new insights into pyroptosis modulation, but
also stimulate the development of novel therapeutics that target gasdermins and pyroptosis. Overall, this
proposal builds upon the PI’s past research program that enables the long-term pursuit of the mechanisms for
gasdermin regulation on a scale that is broadly compatible with the MIRA mechanism.

Public health relevance
Narrative Pyroptosis is a highly inflammatory form of cell death mediated by the gasdermin family members, and is implicated in infections and autoimmune or autoinflammatory disorders. This proposal will leverage our expertise in structural and biochemical studies of gasdermins and inflammatory caspases to investigate the post-translational regulation of gasdermins by proteases, ubiquitin ligases, palmitoyltransferases, and other enzymes. Better understanding of the mechanisms of gasdermin regulation is highly significant, which may stimulate the development of novel therapeutics that target pyroptosis and inflammation.